Non-canonical cGAS signaling in DNA damage response

Project Summary:
Alzheimer's disease(AD) is the most prevalent form of dementia, accounting for approximately 60-70% of all
dementia cases worldwide. It has been increasingly recognized that NAD+ depletion and elevated activity of the
cGAS-STING pathway are implicated not only in normal aging but also in various neurodegenerative conditions,
including Alzheimer's disease. NAD+ metabolite plays a pivotal role in maintaining cellular homeostasis and is
considered one of the crucial hallmarks of aging and neurodegeneration. NAD+ depletion can trigger
mitochondrial dysfunction, inflammation, impaired lysosomal and proteasomal function, compromised adaptive
cellular stress responses, and hinder DNA repair mechanisms. Boosting NAD+ levels in animal models of AD
has been shown to ameliorate pathological features of AD. Interestingly our recent studies have demonstrated
that cGAS-STING activation induces NAD+ depletion in cell culture and mice. Considering this the novel
mechanistic link between cGAS-STING signaling and NAD+ depletion, we propose to gain insights into the novel
crosstalk between cGAS-STING pathways and NAD+ metabolism in the context of AD pathogenesis.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common form of dementia worldwide. Detailed understanding of the molecular processes underlying the development of the disease is critical for future therapeutics. The primary goal of this project is to assess the contribution of pathways involved in NAD metabolism and cGAS-STING pathway.